METABOLIC AND ENDOCRINE DEFICITS IN LEAN NONDIABETIC OFFSPRING OF IDDM PATIENTS

This study is designed to prospectively examine changes in the insulin secretion in first degree relatives of non-insulin dependent diabetics compared with individuals with no family history of diabetes.